Identifying Relapse Predictors and Therapeutic Vulnerabilities in Ph+ and Ph-like Acute Lymphoblastic Leukemia

Abstract
Our overarching goal is to systematically uncover the genomic heterogeneity of pediatric and adolescent/young
adult (AYA) Philadelphia chromosome-positive (Ph+) and ABL-class Ph-like acute lymphoblastic leukemia (ALL)
to 1) identify genetic predictors of relapse and 2) therapeutic vulnerabilities. While the long-term survival rate of
childhood ALL exceeds 90% with contemporary chemotherapy, the outcome of pediatric and AYA patients with
BCR::ABL1-driven acute leukemia remains poor, even with the addition of tyrosine kinase inhibitors. BCR::ABL1
constitutes the canonical oncogenic driver of two hematologic malignancies: chronic myeloid leukemia (CML)
and Ph+ALL. Since 2012, a myriad of ABL-class fusions involving ABL1, ABL2, CSF1R, KIT, LYN, PDGFRA and
PDGFRB was discovered. Patients with ABL-class Ph-like ALL also have poor outcomes, with 5-year event free
survival (EFS) <60%. In addition, a recently recognized Ph+ ALL subset with discordant end-of-induction minimal
residual disease (MRD) response, characterized by the absence of IgH/TCR clones with persistent BCR::ABL1
fusion transcript in non-leukemic cell subpopulations, suggests that the BCR::ABL1 fusion arises from a
multipotent hematopoietic progenitor cell reminiscent of CML. Consequently, these patients are designated as
CML-like and fare poorly with intensive chemotherapy and TKI. There is thus a critical unmet need to improve
outcomes for patients diagnosed with these aggressive leukemias.
Our central hypothesis is that genetic alterations mediating therapeutic resistance leading to clinical relapse
can be identified via a comprehensive multi-omics profiling of a large cohort of patients uniformly treated on a
clinical trial, and these resistance drivers will harbor novel therapeutic targets. We will leverage the unique
resource of patient samples and clinical data collected on Children's Oncology Group (COG) AALL1631, the
largest prospective international study for pediatric/AYA Ph+ and ABL-class Ph-like ALL to date. Using
comprehensive genomic data (funded from other sources) generated from paired diagnostic/germline samples
collected on AALL1631, we will first identify predictors of relapse in Ph+ and ABL-class Ph-like ALL and further
determine the therapeutic value of major secondary events via cell proliferation and pharmacologic inhibitor
screens in engineered cell line models of Ph+ and ABL-class Ph-like ALL harboring these secondary events. We
will test the efficacy of the most compelling candidate compounds in patient-derived xenograft (PDX) models
established from samples collected on AALL1631. Second, we will decipher the molecular and cellular
heterogeneity of CML-like versus typical Ph+ALL via single-cell genomics and functional assays. We hypothesize
that CML-like patients exhibit distinct transcriptomic signatures, mutational profiles, and cellular heterogeneity
compared to typical Ph+ ALL patients that may account for their differential treatment responses, and we will
investigate CML-like phenotypes by performing single-cell RNA-sequencing to determine distinct transcriptomic
and expression profiles that will provide novel opportunities for diagnostic and therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Philadelphia chromosome-positive (Ph+) and Philadelphia chromosome-like acute lymphoblastic leukemia (Ph- like ALL) with ABL-class fusions are aggressive blood cancers of children and adolescents/young adults (AYAs) driven by gene fusions that are associated with constitutive signaling activation, which can initially be treated with specific kinase inhibitors. However, predictors of relapse in this disease are lacking with more than 90% of relapses occurring in patients who respond well with negative minimal residual disease at the end of induction chemotherapy. In the proposed studies, we will analyze genomic data from patients enrolled on AALL1631, the largest international trial to enroll pediatric and AYA patients with Ph+ or ABL-class Ph-like ALL (1) to identify additional genetic events that are enriched in patients who relapse, (2) to perform drug screens using engineered cell line and patient-derived xenograft models to identify new therapies for patients with additional relapsed- associated mutations, and (3) to study differences between `typical' Ph+ ALL versus CML-like ALL that will provide new therapeutic avenues.